Structures of intermediates in cytochrome c oxidase

Cytochrome c oxidase (CcO) plays a central role in mitochondrial energetics. It is the final electron
acceptor in the respiratory chain of mitochondria, which catalyzes the four-electron reduction of
oxygen to water and harnesses the chemical energy to pump four protons across the inner
mitochondrial membrane to establish an electrochemical proton gradient that is used to synthesize
ATP. In humans, CcO activity is intricately regulated by a variety of cellular effectors, such as
hormones, adenine nucleotides and cytochrome c. Despite extensive studies, the mechanisms by
which the oxygen reduction reaction carried out by CcO is coupled to proton translocation and the
activity of the enzyme is regulated by cellular effectors remain poorly understood. It creates a critical
barrier hindering the development of effective therapeutic strategies against the related diseases. The
two major aims of this project are to (i) determine the 3D structures of key oxygen intermediates of
CcO using time-resolved serial femtosecond X-ray crystallography (SFX), thereby delineating the
protein conformational changes associated with the oxygen reduction reaction occurring in the active
site of the enzyme, and (ii) determine the 3D structures of CcO in complex with cellular effectors,
including thyroid hormones, steroid hormones, ADP/ATP, and cytochrome c, using single-particle
cryogenic-electron microscopy (cryo-EM), thereby deciphering the allosteric protein conformational
changes critical for the cellular regulatory mechanisms. The structural studies will be complemented
by activity assays and spectroscopic measurements to establish structure and function relationships
of the enzyme. This project, built on our extensive experience in spectroscopic and structural studies
of CcO, as well as our strong preliminary data in structural determination of CcO with cryo-EM, will
uncover paradigms that greatly enhance our understanding of this important enzyme essential for
life.

Public health relevance
The goal of this project is to determine the structures of cytochrome c oxidase (CcO) by using two state-of-the- art technologies: serial femtosecond X-ray crystallography and single particle cryogenic electron microscopy. The outcome derived from this project will yield important knowledge allowing us to comprehend how the oxygen reaction catalyzed by CcO is coupled to proton translocation and how the activity of CcO is regulated by cellular effectors. This research is relevant to the mission of NIH as it will provide a structural framework to guide the development of novel therapeutic strategies targeting related human diseases.